Defining the role of ILF2-ILF3 in human cell fate

PROJECT SUMMARY/ABSTRACT
Congenital malformations arising from errors during fetal development are the leading cause of infant
death in the United States. Physiologic development relies on an orchestration of gene regulatory mechanisms.
These mechanisms instruct pluripotent cells in the embryo to specify into hundreds of differentiated identities in
the right place at the right time. Thus, to develop therapeutic strategies against developmental diseases, there
is a critical need to understand the gene regulation instructing cell fate. Both transcriptional and posttranscriptional
regulation are known to instruct DNA and RNA processing of genes important in cell fate
specification. Yet, a growing area of study has revealed that these regulatory mechanisms can interact to allow
feedback, competition, or cooperativity between chromatin and RNA functions. However, a significant gap in
knowledge is how this interplay contributes to human cell fate control. Preliminary data indicate that ILF2-ILF3,
a heterodimeric, dual DNA- and RNA- binding protein, is critical for specifying human embryonic cell fates by
regulating splicing of key chromatin regulators. This proposal aims to define the interplay between DNA and RNA
regulation as a novel mechanism of human cell fate control. The following aims are designed to test the
hypothesis that ILF2-ILF3 is a critical determinant of human cell identities through regulation of both
chromatin and RNA. Aim 1 will suppress ILF2-ILF3 expression in two systems of differentiation of human
pluripotent stem cells to test the hypothesis that ILF2-ILF3 is required for early cell fate transitions. Aim 2 will
identify direct chromatin, RNA, and protein binding partners of ILF2-ILF3, and investigate downstream effectors,
to test the hypothesis that ILF2-ILF3 regulates both transcriptional and post-transcriptional processes to specify
cell fate. The long-term obiectives of this project are to determine a new mechanism driving human
development at the molecular and cellular levels and advance strategies to prevent congenital diseases.
This fellowship application is sponsored by Bruno Di Stefano, Ph.D., an expert stem cell biologist, and
Jason Mills, M.D., Ph.D., a physician-scientist and expert in gastrointestinal cell plasticity, who will provide close
guidance throughout the fellowship period. The training plan includes strategies to 1) Learn from accomplished
scientists and physician-scientists that will advise the applicant through her training goals; 2) Undergo rigorous
scientific training in stem cells and gene regulation; 3) Experience opportunities to improve scientific
communication skills and expand professional networks; 4) Advance the applicant's clinical training, especially
in pediatrics. The clinical and scientific training environment at Baylor College of Medicine is within the Texas
Medical Center, the largest medical research complex in the world. This environment is ideal to foster the
applicant's scientific and clinical growth toward a career as a pediatrician-scientist using stem cells to uncover
mechanisms of child development and disease.

Public health relevance
PROJECT NARRATIVE In the United States, congenital malformations and deformations are the leading cause of death in infants. The proposed research aims to uncover novel gene regulatory interactions that specify cell identities during normal development. The objective of this study is to use human pluripotent stem cells to how cell identities are specified, with the ultimate goal to inform new strategies for the treatment and prevention of congenital disorders.